Caribbean Primate Research Center Program

PROJECT ABSTRACT:
A storage area at the Sabana Seca Field Station is urgently needed to accommodate any colony
expansion. To support any increase in housing and research activity, additional storage space
becomes imperative, aligning with our commitment to the efficient and effective utilization of our
facilities. With this administrative supplement to the parent grant, we aim for additional space
that will not only facilitate breeding activities but will also be utilized to expand the environmental
enrichment area and the animal viral testing housing area.

Public health relevance
PROJECT NARRATIVE: The major goal of this administrative supplement application for the Parent Grant P40 of the Caribbean Primate Research Center (CPRC) is to improve and expand the storage and housing areas at the Sabana Seca Field Station. This in turn is essential to support any expansion of the Center's IO rhesus colony. The CPRC is one of the most important national resources for any research program using indian- origin (IO) rhesus macaques with no history of admixture and with well-defined genetic and virological backgrounds. Since 1938, the Center has supplied the scientific community with Indian origin rhesus macaques with known backgrounds and of the same genetic pool for use in studies of basic biology and diseases. In the last three years (2020-2023), 700 animals (app 230/year) have been available from this program in support of NIH-high priority HIV/AIDS-research, mainly R01, P01, U01- funded academic investigators and NIAID-DAIDS-SVEU programs. The CPRC has vast experience in the establishment and maintenance of rhesus macaque breeding colonies. The animal care and use program of the CPRC is in compliance with the directives established by the Animal Welfare Act (AWA), PHS and other agencies. The Center is AAALAC fully- accredited. The population management program has been designed to optimize the health and well-being of the monkeys, enhance the value of the colony for research, and provide healthy animals to the scientific community for a variety of studies. The Center is in the urgent need of creating storage area and to renovate a quarantine housing area needed when SPF candidates animals undergoes viral testing. This renovation will support the CPRC to achieve the objective of the expansion and maintenance of the SPF-P40 colony within the original scope of the parent grant.